Metabolism, Endocrinology, and Obesity Training Grant

Project Summary
The application is to renew the T32 application for a Training Program in Diabetes, Endocrinology and
Metabolic Diseases from Boston University Medical Center that consists of Boston Medical Center and
Boston University Medical School. This Program that has been funded by the NIH since 1964. During this
period, numerous post-doctoral fellows have been trained by this Program, many of whom have gone on
to successful careers in academia. More recently, the inclusion of pre-doctoral trainees has resulted in
their having a similar rate of successful careers in academia. As the composition of the Boston University
Medical Center faculty has changed, and the health problems of the population, local and nationwide,
have evolved over these past ca. 50 years, the translational and basic research focus and strengths of the
program have evolved to meet these changes. Thus, in the current application, we emphasize four
Program areas for the training of post- and pre-doctoral scientists and physician/scientists in which we
have considerable strength. These are: (i) basic (molecular, cellular endocrine and metabolic science
related to obesity and diabetes) (ii) vascular biology and inflammation and its relationship to metabolic
disease (iii) translational studies related to endocrine and metabolic disease (iv) model systems and
organisms in regulation of metabolism. To address the major health-related issues in these areas, trainees
will utilize a variety of relevant animal models, in vitro cell systems as well as bringing a major focus to
human metabolism at both the cellular and organismal levels. Trainees will be able to understand multiple
aspects of metabolic diseases in one or more of the areas noted above, and they will be able to apply this
understanding in a translational fashion to disease prevention, treatment and eventual cure. The need for
such training is underscored by the explosion of metabolic disease, not only in the USA, but worldwide.
The training "team" consists of scientists, clinicians and physician/scientists, in multiple departments at BU
Medical Center, who are highly accomplished, interactive and broadly experienced. Consequently,
trainees will have access to state of the art knowledge, resources and technology provided to them by
cutting edge investigators.

Public health relevance
Narrative Obesity and diabetes mellitus, and their associated pathologies, represent worldwide epidemics with enormous physical and social costs. By training the next generation of translational researchers at the pre- doctoral and post-doctoral levels, we will stem the tide by the prevention and treatment of these metabolic disorders.